Defective HIV proviruses and Persistent Innate Immune Activation

Abstract/Summary
CD4+ T cells and macrophages are infected by HIV and this infection correlates to more proinflammatory
activities that drive HIV comorbidities and end organ diseases. Mechanisms that bias innate immune functions
in HIV-infected cells towards chronic inflammation are poorly understood. We have demonstrated infected
primary resting CD4+ T cells and macrophages harbor defective HIV-1 proviruses that, despite having deletions
and mutations which attenuate provirus transcription, generate HIV-1 RNAs. The immunopathological
consequences of persistent aberrant viral RNA expression have not been addressed. We hypothesize that HIV
infection of CD4+ T cells and macrophages establishes a defective but transcriptionally competent
proviral reservoir that expresses aberrant viral RNAs which perpetuate persistent inflammation. We will
address this hypothesis in three specific aims: 1) Determine if persistent expression of cryptic HIV-1 RNAs
promote innate immune activities; 2) Examine whether HIV-1 and HIV-2 have different propensities for
generating intact proviral genomes and whether this influences immune activation; and 3) Determine if DNA
damage response mechanisms lead to establishment of defective proviruses. Successful completion of these
studies will provide general insights into the impact of HIV-1 persistence and expression in the context of CD4+
T cells and macrophages. Importantly, these studies will provide an understanding into mechanisms that
contribute to HIV-1 comorbidities which persist even with antiretroviral treatments and could lead to new targets
and strategies for treatments to improve the lives of people living with HIV.

Public health relevance
NARRATIVE HIV infection is associated with dysregulated immune cell activities. We are proposing to explore how HIV RNA expression from defective proviruses mediate these inflammatory responses. These studies are relevant for understanding how HIV perpetuates disease even with antiretroviral treatments and could provide new targets and strategies for treatments to improve the lives of people living with HIV.